The Implementation, Adoption, and Sustainability of Ho'ouna Pono

PROJECT SUMMARY/ABSTRACT The 2021 Summer Research with NIDA program will focus on two activities: (1) Data collection and data management on a survey focused on the barriers and facilitators related to the implementation, adoption, and sustainability of a school-based, substance abuse curriculum (Ho?ouna Pono) across Hawai?i Island schools and communities, and (2) Completion of a systematic literature review focused on the use of electronic nicotine delivery systems (ENDS) of Asian/Pacific Islander youth and young adults. The NIDA Undergraduate Intern (Kelsey S. Manglallan) participating in the Summer Research with NIDA Program will be actively involved in virtual survey data collection and preliminary data analysis, and will lead a team of student researchers in the preparation of the ENDS literature review. This proposed manuscript builds off of her prior work on two related, co-authored manuscripts currently under peer review in two journals (Experimental and Clinical Pharmacology and the Journal of Ethnicity in Substance Abuse). Pending the reopening of public schools for in-person learning, Ms. Manglallan will also participate in onsite data collection within public middle/intermediate schools on Hawai?i Island.

Public health relevance
PROJECT NARRATIVE This internship will contribute to the development of the next generation of underrepresented minority scholars by providing structured research experiences for Ms. Kelsey S. Manglallan. It will provide her with training in community-based participatory research, survey data collection and management, and systematic literature reviews.